An open-source software for Bayesian neuroimaging data analysis

DESCRIPTION (provided by applicant): Neuroimaging is widely used to study neurodegeneration, neurodevelopment, neuropsychiatry, and brain cognitive function. In neuroimaging-based studies, the focus of study often centers on elucidating associations between brain structure or function measurements and clinical measurements. We refer to this as neuroimaging marker detection because its goal focuses on identifying neuroimaging markers characterizing a brain disorder or a cognitive process. Statistical analysis methods play a crucial role in inferring the associations among brain structure or function measurements and the clinical variable. The dominant approach for neuroimaging marker detection is general linear model (GLM) based and mass- univariate. The limitations of this approach are its focus on functional segregation, its inability to model multivariate interactions among brain regions, the assumption of normality, the cut-off threshold problem, and the restriction of detecting linear associations. To address these limitations, we have developed a Bayesian statistical analysis method, called Graphical-model-based Multivariate Analysis (GAMMA), for neuroimaging marker detection. The differences between GAMMA and GLM-based mass-univariate methods are three-fold. First, GAMMA is nonparametric: it does not rely on statistical assumptions, such as normality. Second, GAMMA is multivariate, whereas general-linear-model based methods are mass-univariate. GAMMA has the potential to detect nonlinear, multivariate associations among brain regional structure or function measurements and the status of a clinical variable, which would not be detected by univariate approaches. Third, GAMMA is fully automated: it requires minimum user input, such as region-of-interest (ROI) specification or a predefined significance threshold. Other features of GAMMA include the explicitly modeling of spatial correlations among voxels and model stabilization mechanism. We have applied GAMMA for structural magnetic resonance (MR) image analysis, function MR analysis, and lesion-deficit analysis. GAMMA has been under-utilized due to the lack of resources to improve the usability and interoperability. The goal of the present proposal is to develop an open-source and well documented Bayesian neuroimaging data analysis software with enhanced usability, interoperability, and accessibility. The specific aims are: Specific Aim 1: Enhance the software's reporting, project management, and visualization module. This specific aim focuses on designing a graphical user interface (GUI). This GUI can present the results generated by GAMMA in a readily understandable and interpretable fashion for other investigators. This GUI also supports project management and visualization. Specific Aim 2: Enhance the software's ability to support various image and data file formats. This specific aim includes providing support for analyze, NIFTI, and DICOM image format;add support module to read clinical variables in CSV (Comma Separated Values) format and XML (Extensible Markup Language);and output the generated statistical model in a format that is widely used by data mining community. Specific Aim 3: Ensure interoperability between GAMMA and widely used neuroimaging data-analysis tools. We will develop a SPM5-GAMMA toolbox;write user-manual sections that describe how to use GAMMA to analyze the results generated by AFNI or FSL, and how to visualize GAMMA's output using AFNI or FSL;and develop a GAMMA application programming interface (API) to facilitate users to incorporate GAMMA into their software. Specific Aim 4: Completely document the application, providing user and developer's manuals. We will provide source code, toolbox, developer toolkit, sample test data, pre-compiled end user software for different platforms, and documentation in NIH Neuroimaging Informatics Tools and Resources Clearinghouse (NITRC), in order to share it with scientific community. PUBLIC HEALTH RELEVANCE: This project centers on enhancing an open source Bayesian data mining tool to analyze neuroimaging data. This tool can identify neuroimaging markers characterizing a clinical condition in the study of neurodegeneration, neurodevelopment, neuropsychiatry, and brain cognitive function.

Public health relevance
This project centers on enhancing an open source Bayesian data mining tool to analyze neuroimaging data. This tool can identify neuroimaging markers characterizing a clinical condition in the study of neurodegeneration, neurodevelopment, neuropsychiatry, and brain cognitive function.